Pathogenesis of Fever in Man

Project Summary/Abstract
Interleukin-38 (IL-38), a member of the IL-1 family, has not been studied until recently despite its discovery
20 years ago. It is a neglected cytokine because no receptor was identified for how IL-38 functioned.
However, in 2012, we reported that recombinant human IL-38 bound to the IL-36 receptor (now IL-1R6) and
suppressed the production of IL-17 and IL-22. In that study, we proposed that IL-38 acted as a receptor
antagonist for IL-1R6. However, the dose-response of IL-38 did not behave as receptor antagonist but rather
acted as an inhibitor of cell activities. New data suggests that IL-38 requires IL-1R6, an orphan receptor in
the IL-1 Family, to suppress IL-17. Formerly termed IL-1 Receptor Associated Protein Like-1, IL-1R9 will be
studied for its putative role in the suppression of innate immunity by recombinant IL-38. Using CRISPR/Cas
methods, we have generated a colony of mice that are deficient in IL-38. These mice are used to determine
a requirement for endogenous IL-38 in mouse models of human inflammatory diseases. In those models
where disease severity worsens in IL-38 deficient mice, we will use recombinant IL-38 to treat mice for
suppression of innate inflammation. In order to fully understand the role of IL-38 in innate immunity, we
generated a mouse colony deficient in IL-1R9. We will study the requirement of IL-1R9 for the function of
recombinant IL-38 in those mouse models where treatment with IL-38 has significantly reduced disease
severity. A unique aspect of this application is that IL-1R9 in on the X-chromosome, an unusual finding in
cytokine biology. Because IL-1R9 is on the X-chromosome, we can address how suppression of innate
immunity is affected in males compared to females. With most autoimmune diseases having a 70%
predilection for females and with each autoimmune disease there is an inflammatory contribution, we have
designed studies for comparisons of homozygous IL-1R9 deficient males to homozygous IL-1R9 females.
In these studies, we will also evaluate the role of IL-38 to inhibit the activation of the NLRP3 inflammasome
using a specific oral NLRP3 inhibitor presently used to treat patients. In addition to AIM 1 and AIM 2 studies
on recombinant IL-38 suppression of innate immunity and the putative role of IL-1R9, we will produce and
test an IL-38-Fc fusion protein (AIM 3). The rationale for producing an IL-38-Fc fusion protein is to provide
pre-clinical data for an IL-38 therapeutic. In AIM 4 we address the issue of IL-38 release from the cell. IL-38
circulates in healthy subjects but levels are significantly low in subjects at risk for a cardiovascular events.
However, IL-38 being a B-cell product suggests that processing of the IL-38 precursor and release from the
cell is not via traditional pathways. We will examine pathways for secretion that are used by other members
of the IL-1 Family : inhibition of NLRP3 and inhibition of calpains. The overall goal of these studies is to
advance the biology and clinical significance of IL-38 as well as to exploit the anti-inflammatory properties of
IL-38 as a therapeutic.

Public health relevance
Project Narrative Interleukin-38 is a small protein made by the body in response to inflammation or an infection. Interleukin-38 reduces inflammation. The project will produce Interleukin-38 a therapeutic to treat various inflammatory diseases in humans.